Surrogate Augmented Deep Predictive Learning for Retinopathy of Prematurity

Surrogate Augmented Deep Predictive Learning
for Retinopathy of Prematurity
ABSTRACT
This proposal aims to develop novel surrogate augmented deep predictive learning algorithms for predicting
retinopathy of prematurity (ROP). The proposal directly addresses a critical clinical burden in ophthalmology that
limited ROP experts are available in the United States and worldwide, yet the early detection of ROP for timely
treatment has tremendous clinical benefit for infants in preventing childhood blindness. Using a unique and
massive dataset with 7905 image sets collected from a longitudinal observational study of 1257 premature
infants from 13 centers in North America, we plan to develop, validate, and evaluate novel analytic algorithms
that hold a promise of directly improving clinical practice in the ROP care of premature infants.
The overarching goals of this proposal are: (1) to develop novel methods for performing risk stratification through
the surrogate augmented deep predictive learning of earliest retinal images (prior to 34 weeks postmenstrual
age [PMA]) and the most important ROP risk factors (birth weight, gestational age) for early prediction of
referral-warranted ROP (RW-ROP), defined as plus disease, ROP in zone I, or stage 3 ROP or greater; and (2)
to optimize the ROP schedule through the surrogate augmented deep predictive learning of accumulated
longitudinal retinal images for the dynamic prediction of RW-ROP. Our methods, after proper validation in
future prospective studies, may serve as a useful tool for ROP risk stratification and optimization of scheduling
of ROP examinations, which can reduce the burden of ROP examination for both infants and ophthalmologists
while improving the eye care of premature infants for the prevention of childhood blindness.
The Specific Aims to achieve these goals are:
Aim #1: Develop and evaluate the surrogate augmented deep predictive learning of the earliest retinal
image sets taken prior to 34 weeks PMA and demographic factors to predict RW-ROP. Accurate risk
stratification through earlier prediction of RW-ROP will help identify high-risk infants for close follow-up by
ophthalmologists for early detection and timely treatment of ROP, and low risk infants who are currently receiving
unnecessary physically stressful retinal examinations for less frequent ROP examinations.
Aim #2: Implement the surrogate augmented deep predictive learning of accumulated retinal images
over time to dynamically predict RW-ROP. The dynamic prediction of the future course of ROP by deep
learning of longitudinally accumulated retinal images will help optimize the schedule of ROP examinations by
ophthalmologists, thus reduce the burden of ROP examinations for both infants and ophthalmologists.
The successful completion of this project will lead to novel analytic algorithms of retinal images for early
identification of high-risk infants for close follow-up and for optimization of ROP exam schedule, which will lead
to earlier detection and timely treatment of ROP while minimizing the number of ROP exams. This research is
highly feasible and potentially transformative in its global impact on the ROP care of premature infants.

Public health relevance
Project Narrative The proposed project will develop and evaluate the surrogate augmented deep predictive learning of earliest retinal images (taken prior to 34 weeks postmenstrual age) for the early prediction of referral-warranted retinopathy of prematurity (RW-ROP), and implement the surrogate augmented deep predictive learning of longitudinally accumulated retinal images for the dynamic prediction of RW-ROP.